Administrative Core

PROJECT SUMMARY (See instructions): The Administrative Core (Core D) will provide organizational and administrative support to facilitate communications, reporting, budget management, and other tasks that interface with the three projects and the three scientific cores. The administrative core will include Dr. Pamela J. Bjorkman as Core Leader, her Administrative Assistant, and a Research Scientist in her lab. Also included is the Administrative Assistant in Dr. Michel Nussenzweig's lab. The Core D staff will be responsible for arranging formal communications among investigators, preparing protocol submissions and annual renewals to the Institutional Review Boards, coordinating material transfer agreements, preparing reports and manuscripts, monitoring budgets, and generally overseeing the scientific and administrative needs ofthe Program Project.

Public health relevance
RELEVANCE (See instructions): Successful management of this program project will facilitate goals of relevance to the understanding and treatment of HIV/AIDS.